Induction of tolerance to FVIII by engineered T regulatory cells in hemophilia

Abstract
The major effort in our lab has been to develop and translate novel therapies to prevent and reverse
adverse immune repsonses, with the ultimate goal of clinical translation, for example, in monogenic
diseases like hemophilia A (HA), but also in autoimmunity and allergy. These tolerogenic approaches
include B-cell delivery of Fc-fusion proteins and nanoparticles that we have shown can lead to the
activation of antigen-specific regulatory T cells (Tregs). During the last four years, our focus in HA has
emphasized the production and validation of novel engineered specific regulatory T cells that express
either a FVIII-specific T-cell receptor (TCR) or a single chain variable fragment (scFv) chimeric receptor
(Kim et al., 2015, Yoon et al. 2017). The TCR-transduced Tregs are MHC-restricted and recognize
FVIII-peptide on antigen-presenting cells. On the other hand, scFv-expressing Tregs (CAR-like)
respond to conformational epitopes on cell surfaces. Recently, we developed an additional approach to
inhibit/kill the FVIII-specific B-cells that give rise to plasma cells, using both Tregs and CD8+ T cells that
express FVIII domains (Zhang et al. 2018). We named the latter cells “BAR” for B-cell-targeting
Antibody Receptor. The latter T cells express a chimeric receptor (CAR), comprised of a protein antigen
or its domain, linked with the transmembrane and signal transduction domains, CD28-CD3ζ, like the
above two CARs. The three types of engineered chimeric receptor T cells can strongly block the anti-
FVIII immune response in vitro and in vivo, and recent data suggest that BAR Tregs can suppress the
symptoms of anaphylaxis in the presence of circulating antibody. Based on the success of our
approaches, our goals in this renewal are to further analyze and optimize the ability of these different
engineered Tregs to suppress not only primary but also ongoing anti-FVIII responses in vitro and in
vivo. We will also analyze the cellular targets and molecular mechanisms by which these engineered T
cells suppress specific antibody formation in hemophilic mice as well as in B-cell receptor transgenics.
Evaluating their long-term efficacy in vivo in the presence of circulating antibody is an important goal.
These studies will provide proof of principle for the utility and mechanism of action of engineered Tregs
and provide steps for clinical translation.

Public health relevance
Narrative Our lab has focused on developing approaches to prevent or even reverse adverse immune responses, such as inhibitor formation to therapeutic factor VIII in hemophilia. We have previously engineered human regulatory T lymphocytes (called Tregs) with antigen-specificity to induce tolerance to modulate these adverse immune responses. In this proposal, we will analyze three novel murine Tregs specific for FVIII. We will determine their function in the presence of inihibitors and study their stability and mechanism of action, and as a step for future clinical translation.